CRCNS: Computations and Neural Mechanisms in Sustained Perception in Humans

Studies of human perception mostly focus on neural responses to short stimuli and specifically on their
initial recognition. How the brain supports sustained perception of longer stimuli is poorly understood. The
fundamental novelty of our project is in addressing this neglected segment of human perceptual
experience. We recently discovered that distributed neural representations of stimulus category persist for
the duration of the stimuli in ventral temporal cortex, whereas in fronto-parietal cortex the stimulus
category could only be decoded shortly after stimulus onset. These findings motivate our Specific Aims: 1)
How does attention and awareness affect persistent representations of visual stimuli? 2) What is the
structure and information content of field potentials and single neuron spikes in individual brain regions
and how do they interact during sustained perceptual experience? 3) What are the computational
principles and mechanisms underlying sustained perception? The project is embedded in the Pis long
term goals of understanding the electrophysiological and computational basis of perception, attention and
awareness. We will use advanced computational methods and unique intracranial data of local field
potentials (LFP) and single units (SU) from human patients, combining novel experimental paradigms,
data analysis and decoding approaches, and modeling and analytic frameworks. The project will provide
training to graduate and undergraduate students in interdisciplinary, collaborative research on
fundamental issues in neural computations and cognition, with cross-site visits to develop new
approaches and discuss results.

Public health relevance
RELEVANCE (See instructions): Understanding the continuity of visual experience is a fundamental problem in the fields of vision, visual perception and visual consciousness. The proposed research will elucidate both local computations and communication between distributed brain networks supporting sustained visual perception The work will provide tools and theory for studying both normal and disordered visual processing and guidance for development of novel rehabilitation methods.